Primary Care Research Methods & Statistics Conference

[unreadable] DESCRIPTION (provided by the applicant): Primary Care Research Methods & Statistics Conference (12/5-7/2008, 12/4-6/2009, 12/3-5/2010). Background. There is a continuing need to expand research capacity in the primary care setting. Purpose. The purpose of the Primary Care Research Methods & Statistics Conference is to increase capacity in primary care research by: 1) helping novice researchers develop basic research skills; and 2) helping experienced researchers expand their repertoire of research methodologies. Methods. For novice researchers, the conference is designed to help develop basic research skills such as planning, conducting, and communicating results of simple research studies. This goal will be addressed through the Novice Researcher Workshop, the basic Methodology track, the AHRQ Review of Concept Papers Workshop, the Research Career Planning panel discussion, and opportunities for networking with intermediate and experienced researchers present at the conference. For experienced researchers, the conference is designed to expand their repertoire of research techniques and statistical approaches to help them conduct high quality, sophisticated studies addressing complex questions in primary care. This goal will be addressed through the pre-conference Experienced Researcher Workshop (usually on an advanced statistics topic), the Statistics track, the Thematic track, the Dissection of Innovative Studies Workshop, the Plenary Sessions, and the Methodological Think Tank process. Evaluation. Each conference session is evaluated by attendees and a session Moderator. The Moderator also evaluates the presenter's speaking abilities. Finally, each attendee is asked to complete a summative evaluation of the conference, which also solicits their input regarding future conference themes, potential speakers, and possible content tracks. Evaluations are collated and considered by the multidisciplinary Program Committee during the planning stage of each year's conference. Marketing and Dissemination. The applicant and co-applicant have arranged working relationships with leaders in Internal Medicine, Pediatrics, Family Medicine, Health Services Research and Nursing Research to market the conference to primary care researchers around the country, recruiting them both as presenters as attendees at the conference. These same leaders will help the applicant and co-applicant disseminate program results to a wide audience of primary care researchers, using a variety of means, including professional society newsletters, email listserves, websites, and professional annual meetings. [unreadable] [unreadable] [unreadable] [unreadable]